Circulating immunoactive small RNAs in COPD as biomarkers.

PROJECT SUMMARY
The overall goal of the application is to characterize the expression pattern of a novel class of circulating short
non-coding RNAs (sncRNAs) in chronic obstructive pulmonary disease (COPD) using biospecimens available
from the Biological Specimen and Data Repository Information Coordinating Center (BioLINCC). COPD is the
most prevalent lung disease worldwide and ranks as the sixth leading cause of death in the United States. COPD
is primarily caused by cigarette smoking and long-term exposure to harmful substances. Patients gradually
develop the symptoms over time, lacking the opportunity for early diagnosis and timely intervention. Therefore,
discovering early markers can be expected to prevent the progression to a life-threatening condition. We recently
discovered novel circulating short non-coding RNAs (sncRNAs) that are upregulated in plasma obtained from
patients with COPD. These RNAs are derived from 5′-half regions of tRNAValCAC and tRNAHisGUG. We
demonstrated that these tRNA-derived sncRNAs activate human macrophages leading to cytokine productions,
designating them as immunoactive RNAs, immR-Val and immR-His. Due to the high specificity of immR
expression in patients, they hold potential for use as early diagnostic biomarkers for immRs and as inflammatory
mediators associated with the progression of the disease. This previous study was conducted with a small cohort,
to gain a comprehensive understanding of the expression profiles of immRs associated with COPD pathogenesis,
it is imperative to use a larger number of clinically validated samples. We will obtain plasma samples from the
Subpopulations and Intermediate Markers in COPD Study (SPIROMICS), a nationwide study of COPD that
involves the mass collection of biospecimens. In this proposal, with over 300 plasma subjects, we will quantify
the levels of immR-Val and immR-His by using our original method of TaqMan-based qPCR that allows a specific
detection of target immRs from a trace amount of input RNA (Aim 1). The samples are classified into four
categories based on a GOLD (Global Initiative for Obstructive Lung Disease) criteria, and we will assess whether
the expression profiles of immRs are evident with the GOLD classification (Aim 2). In addition to this, we will
stratify the immRs expressions based on the other patient characteristics, including age, gender, COPD severity,
cigarette smoking status (duration of smoking, frequency, whether they are current smokers or have ceased
smoking), and clinical parameters (BMI, duration since being diagnosed with COPD, spirometry results,
medication history, and frequency of exacerbation). Our objective is to develop a comprehensive understanding
of immRs through the proposed aims, providing robust evidence demonstrating the clinical associations of
immRs with COPD pathogenesis.

Public health relevance
PROJECT NARRATIVE The primary causative factor of chronic obstructive pulmonary disease (COPD), the most prevalent lung disease worldwide, is cigarette smoking and long-term exposure to harmful substances, making the discovery of early biomarkers essential to prevent its progression to a life-threatening condition. We recently discovered that novel small RNA molecules derived from tRNA are upregulated in the plasma of COPD patients that can activate human macrophages. In this proposal, we will investigate the expression profiles of these immunoactive RNAs using a large cohort of plasma samples and comprehensively characterize their clinical associations with COPD pathogenesis.